Administrative Core

PROJECT SUMMARY / ABSTRACT – Administrative and Mentoring Core
In Phase 1 of the COBRE-Diabetes, the Administrative and Mentoring Core (AMC) developed novel and effective
administrative strategies to coordinate the management of the Diabetes Research Center (DRC) at the University
of Hawaiʻi. The AMC designed a successful multi-level mentoring approach for the Research Project Leaders
(RPLs) and Pilot Project Leaders (PPLs) that included: mentors, peer-to peer mentoring, the Advisory Committee
(AC), and Clinical Internal Advisory Board. The overall goal of this core, in alignment with the overall DRC
proposal, is to build a self-sustaining Diabetes Research Center that will improve current and future
research competitiveness and broaden the research breadth and trans-disciplinary scope of diabetes
(DM) and insulin resistance (IR) studies and future diverse scientists in Hawaiʻi. The emphasis of the AMC
is the coordination of all the resources to mentor and facilitate research for the RPLs and PPLs. This will be
accomplished through Specific Aim 1 which is to effectively coordinate and manage a center of excellence
dedicated to DM/IR. The AMC oversight will be conducted by Director, Mariana Gerschenson, PhD and Deputy
Director, Dr. Marjorie Mau, MD. The Executive Committee also includes the Metabolic and Analytic Core Director
and Co-Director: Olivier Le Saux, PhD and Alexandra Binder, ScD and the Pilot Project Program Co-Directors:
Takashi Matsui, MD, PhD, and V. Andrew Stenger, PhD. The team and RPLs obtain advice from the AC. The
Clinical Internal Advisory Board (CIAB) provides the RPLs with clinical scientific advice on diabetes regarding
the approach and analysis of their projects. Community Engagement will be led by Dr. Mau and will consist of a
2-day conference that will prominently feature our DRC investigators as well as community-recommended topics
such as diabetes management updates and the latest prevention strategies. In addition to an annual DM-focused
conference, the DRC leadership will initiate a more active presence on our website and social media platforms.
In Specific Aim 2, the Administrative and Mentoring Core will help each RPL develop an individual mentoring
plan. All mentors and mentees (RPLs and PPLs) will have training sessions on the best mentoring practices
including: Mentor Training, Managing Mentoring Relationships, Unconscious Bias, and Launching Research
facilitated by the Center For the Improvement of Mentored Experiences in Research (CIMER) and the National
Research Mentoring Network (NRMN). The Mentoring Team, Executive Committee, and the EAC will help each
RPL develop a detailed mentoring plan with the specific goal that the RPLs graduate within three years. In
Specific Aim 3, the COBRE-Diabetes Phase 2 will continue our Pilot Project Program that will stimulate and
advance extramural funding of meritorious diabetes proposals and assist researchers to develop into future RPLs.
An important component of scientific success in the COBRE-Diabetes is through collaborations and this will be
encouraged in the Pilot Project Program.